Administrative Core

Project Summary:
The Administrative Core for this Metabolic Basis of Disease (MBD) center will support the mentoring and career
development of the research project junior faculty. In addition, the Administrative Core will be responsible for
overall leadership and management of the MBD center. The primary effort will be focused on facilitating
mentorship and career development of the Research Project faculty as well as coordinating expansion of our
scientific infrastructure. This approach will enable us to promote the biomedical research discoveries that
advance our understanding of the etiology and underlying causes of metabolic aspects of different disease
states. The MBD Center administration will be located on second floor of Basic Science Building where the
Project Director and administrative assistant are in very close proximity. In addition, three of Research Projects
have laboratory space on this floor. The Center Director (Stephens), Associate Director (Morrison), the
Preclinical Core, the Molecular Mechanisms Core, and the Research Project PIs are all housed in this building
and this will greatly facilitate communication and day-to-day interactions between all members. The Internal
Advisory Committee (IAC) will provide oversight of the goals and mission of the Center (see Overall Research
Plan). The IAC consists of seven faculty members who have substantial mentoring experience and expertise in
scientific core management and method development. The administrative core will also oversee the coordination
of the scientific cores, the Internal and External Advisory Committees, and all other aspects of related to
administration of the center.